Decoding the Interferome by Mapping Genetic Interactions in Human Tissue

PROJECT SUMMARY
Non-immune cells greatly outnumber professional immune cells in the body, providing intracellular pathogens
with many opportunities to shelter and take refuge. How does the immune system protect this huge landscape?
My previous work described the ability of the immune cytokine interferon-g (IFN-g), classically considered a
macrophage activating protein, to broadly activate non-immune cells and confer the ability to mount sterilizing
cell-intrinsic responses through effectors encoded by Interferon-Stimulated Genes (ISGs), collectively termed
the ‘interferome’. However, our understanding of how ISGs execute tissue localized responses is in its infancy,
with remarkably few of these effectors being well characterized and virtually nothing known about how multiple
ISGs functionally interact to achieve host defense. The principal barrier to understanding ISGs is that they rarely
work in isolation; rather they are part of complex genetic networks that are buffered from the phenotypic effects
of perturbation. I propose a radical new strategy that exploits this genetic complexity by mapping functional
relationships between ISGs using combinatorial forward genetic screens. My central hypothesis is that
systematically mapping genetic interactions will uncover the effectors of localized IFN-g signalling and enable
hierarchical organization of ISG products into functional complexes and pathways (network) that execute specific
protective and pathological responses. On a small scale with a single query gene in my postdoctoral work, this
approach unveiled a pair of synergistic ISGs that execute unexpectedly potent bactericidal defense of the
cytosol. Further development of this technology for use at a larger scale in my own lab will provide the framework
to fully deconvolve the interferome into distinct host resistance pathways. I will develop an experimental pipeline
that enlists a pooled CRISPR-based screening system for multi-locus gene perturbation paired with a novel
single cell imaging and expression analysis platform. Focusing on the human airway epithelium, this innovative
approach will be applied to dissect the ISG-encoded effectors that mediate cell-intrinsic control of three diverse
pulmonary pathogens (C. pneumoniae, B. pertussis, and RSV), and those that mediate lung tissue damage
downstream of cytokine storm. Newly identified ISGs and their connections will be validated for their protective
or pathological activities using tissue explant systems from donated human lungs and models of human lung
organoids. The ensuing genetic interaction network will provide unprecedented insight into the effectors that
dictate infection outcome in the human lung during type 1 immune responses. These findings will reveal new
local therapeutic targets and establish a paradigm for appreciating the full spectrum of immunity. The
approaches pioneered here will also extend to the downstream effectors of other non-immune cells and tissues
whose integrated study will define a new biological landscape of critical importance to human health.

Public health relevance
PROJECT NARRATIVE Supplemental to its classic role as macrophage activating protein, the cytokine IFN-γ has emerged as a critical mediator of barrier immunity, mobilizing elaborate transcriptional programs within non-lymphoid tissues to combat infection. However, the functions, molecular activities, and regulatory circuits of the interferon-stimulated genes (ISGs) that serve as the effectors of this response are largely a mystery. Focusing on the human lung epithelium, I develop an experimental pipeline to map a functional genetic interaction network that underpins the ability of IFN-γ to restrict different classes of pathogens while balancing pathological tissue damage.